Supplement: Recombinant microRNAs in xenobiotic metabolism and disposition

PROJECT SUMMARY
This Administrative Supplement to ongoing R35GM140835 award is to seek for purchasing a new liquid
chromatograph (LC) system that will be used to determine the purity of novel recombinant microRNAs
(BioRNAs) generated through in vivo fermentation production and accurately quantitate target
xenobiotic/drugs and metabolites in complex biological samples. These studies are critical elements in the
MIRA award which will establish the role and importance of microRNAs in posttranscriptional regulation of
xenobiotic metabolism and disposition.

Public health relevance
PROJECT NARRATIVE This administrative supplement to the ongoing R35GM140835 award is to acquire a new analytical HPLC system that will be used for accurate and sensitive analysis of bioengineered polynucleotide molecules as well as drugs/metabolites involved in this project.